Preclinical development of a nuclear-targeting biologic that safely increases stem cell expansion in vivo to accelerate recovery from neutropenia after chemotherapy and bone marrow transplant

Hematopoietic stem cell (HSC) transplants (HSCTs) are considered a potentially curative option for patients with
certain cancers of the blood and bone marrow and over 20,000 HSCTs are performed in the US each year.
However, HSCTs are associated with high risk due to the required removal of diseased bone marrow before
transplantation. Until the transplanted cells engraft and proliferate enough to reconstitute the patient’s immune
system, the patient is considered neutropenic during which they are highly susceptible to infection. In addition to
the potentially life-threatening physical risk to the patient, neutropenia necessitates long hospitalization time that
can in part drives the expensive cost of HSCTs ranging up to $400,000 in the US. A current strategy in clinical
trials is to transplant larger pools of donor HSCs to shorten the neutropenic phase. However, these approaches
all rely on ex vivo culturing of donor cells that depend on imperfect man-made culture systems that may disrupt
the proper function of the stem cells and can be prohibitively expensive. Ship of Theseus’ innovative solution is
a drug that will be used for a brief, one-time exposure to donor cells prior to transplantation that improves
expansion in vivo. Our drug is a patented mutant of nuclear transcription factor, Homeobox protein B4
(HOXB4(m)), which promotes HSC expansion without differentiation. HOXB4(m) has improved degradation
resistance, which enables us to overcome several shortcomings of HOXB4 (e.g., short protein half-life and
myeloproliferative disorders associated with genetic overexpression). By elongating its intracellular half-life,
HOXB4(m) is practical for clinical use while potentially avoiding adverse effects induced by constitutive
overexpression. Early preclinical data indicating treating cells with HOXB4(m) can expand all major lineages of
HSCs while maintaining multipotency. However, current delivery of HOXB4(m) is limited by its ability to penetrate
cells and localize in the nucleus, the site of its bioactivity.
The goal of this R61/R33 proposal is to improve efficiency and safety of HOXB4(m) by improving its nuclear
delivery. This will be accomplished through the execution of 3 aims. In Aim 1 (R61), we will perform a library
screen to identify optimal combinations of cell penetrating peptide and nuclear targeting motifs for HOXB4(m)
nuclear localization. In Aim 2 (R33), we will assess in vitro efficacy of the top candidates to select a lead
candidate. In Aim 3 (R33), we will demonstrate long-term hematopoietic reconstitution without adverse effects
or GVHD of our lead candidate in vivo in a mouse HSCT study. Successful completion of this R61/R33 program
will demonstrate feasibility of an improved HOXB4(m) candidate that maintains efficacy at lower concentrations
and briefer exposure periods. This project will provide the necessary data to support future extensive in vivo
efficacy and safety studies necessary for an IND submission. With HOXB4(m), we can circumvent the original
hurdles of HOXB4 and improve expansion in vivo to benefit HSCT patients by shortening the neutropenic phase
to reduce infection, hospitalization time, and cost.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell (HSC) transplants are used to treat certain cancers of the blood and bone marrow. Diseased bone marrow is removed and replaced with healthy cells, but patients are at high risk for infection and other life-threatening inflammatory conditions until the healthy cells expand enough to restart the immune system. Ship of Theseus is developing therapeutic strategy to shorten this window of risk and improve patient outcomes by developing a novel and safe drug, HOXB4(m), that improves HSC expansion within the patient.